DOUBLE BLIND SAFETY 7 EFFICACY OF ZOLEDRONATE VERSUS AREDIA IN BONE METASTASES

Zolendronate, a third generation bisphosphonate, has been demonstrated to be a potent inhibitor of osteoclasts. It has the largest therapeutic ratio between the desired inhibition of calcium resorption and the unwanted inhibition of mineralization in vitro of all the bisphosphonates. The primary objective of this study is to determine if a dose-response relationship for zolendronate treatment in conjunction with standard antineoplastic therapy exists in patients requiring radiation therapy to bone. It will also assess the efficacy of zolendronate therapy versus that of Aredia and its safety and tolerability versus that of Aredia.